A State-Feedback Neurodynamic Model of Echolocation in Blind Humans

PROJECT SUMMARY
For the 40 million people worldwide who are blind, everyday activities like navigating a room, identifying a
building, or catching a bus present major challenges, especially in unfamiliar areas. Some blind individuals
augment their perception to a remarkable degree via active echolocation, producing a “click” sound with their
tongues to perceive the object and spatial data encoded in the returning echoes. Echolocation is a useful
perceptual and mobility aid for blind persons and a unique scientific model to studying fundamental neural and
perceptual mechanisms. Yet it remains incompletely understood, understudied, and thus rarely taught,
rendering it inaccessible to the majority of untrained people who are blind or visually impaired.
The goal of the proposed research is to characterize the neural dynamics underlying active echolocation. It is a
unique sensing modality that consistently activates various occipital “visual” cortical regions in blind
echolocators, but the dynamics of that brain activity, and its relationship to active click production, is poorly
understood. Here we propose to leverage the fine-grained temporal resolution of magnetoencephalography
(MEG) to trace the dynamics of echolocation processing and to determine the roles and processing circuits for
active echolocation signals. We will recruit blind and sighted participants and record MEG as they listen to
echo stimuli and actively ensonify virtual reflecting objects in the scanner. We will use these data to propose a
model of echolocation incorporating the active click production, sensory feedback from the echoes, and
relevance to a behavioral goal. The results will inform theories of active perception, which currently lack well
defined models in audition; neuroplasticity in blindness, which underrepresents temporal dynamics; and
eventually orientation and mobility training, which lacks evidence to motivate echolocation-based interventions.
Methodologically, in performing the proposed work, we will pioneer temporally resolved neuroscience of
echolocation, expand the application of artifact-reduction algorithms, and introduce a novel framework for
studying auditory sensory-motor coupling paradigms.

Public health relevance
PROJECT NARRATIVE Active echolocation helps blind persons surmount everyday challenges like navigating an unfamiliar path or identifying a building, but many gaps remain in the understanding of its mechanisms. The proposed research would trace and model the neural signature of echolocation as it propagates throughout the brain with millisecond precision, from vocalizating a pulse, to processing its echo, to modifying subsequent pulses pursuant to a task goal. This research will advance imaging methods, elucidate the role of brain plasticity in sensory loss, yield a fuller understanding of active echolocation, and potentially inform training and other interventions to improve the independence of blind and visually impaired people.